Estimates of Resident Population for Counties

To develop the following three products of estimates of resident population for
counties:

1a. Vintage 2022 estimates (based on new proportions)- county population estimates by
single year of age (0-84) and 85+ (summed), sex, bridged race, and Hispanic origin for
April 1, 2020 (estimates base) and annually July 1, 2020-2022

1b. Vintage 2022 estimates (based on old proportions)- county population estimates by
single year of age (0-84) and 85+ (summed), sex, bridged race, and Hispanic origin for
April 1, 2020 (estimates base) and annually July 1, 2020-2022

2. 2000-2010 Intercensal Estimates - county population estimates by single year of age (0-84) and 85+ (summed), sex, race alone or in-combination, and Hispanic origin for April 1, 2000 (2000 Census); annually July 1, 2000-2009; and April 1, 2010 (2010 Census)